Structural and Functional Studies of Chromatin

Project Summary
Chromatin dynamics play a critical role in many cellular processes, including gene expression, DNA
replication, DNA repair, cell division and differentiation. These processes require changes to
chromatin structure, which are regulated by a variety of molecular mechanisms, such as histone
modifications, ATP-dependent chromatin remodeling or transcription factors activity. My laboratory
studies the dynamics of active and silent chromatin states, using structural biology, biochemistry,
molecular biology and genetics. My lab’s research has currently two primary themes, stemming from
our previous functional and structural work on chromatin. The first theme focuses on the biology of
repetitive elements. We combine genetics, genomics and molecular biology to understand how
genomes can differentiate their own (self) DNA from foreign (non-self) DNA such as transposable
elements. In this theme we also study the role of rDNA chromatin in ribosome biogenesis. The
second theme focuses on the mechanisms of chromatin dynamics and modifications. We combine
structural biology with biochemistry and molecular biology to understand how chromatin dynamics
and histone modifications modulate cooperative binding of transcription factors and how the latter
cooperate with ATP-dependent chromatin remodelers to increase accessibility of DNA their binding
sites. Another interest of the laboratory is the dynamics of DNA movements on nucleosome by
chromatin remodelers. We are uniquely positioned to probe those fundamental questions by
combining various approaches, ranging from structural biology to cell biology and genomics, and we
will continue to push the boundaries of cryo-EM beyond static structures. Our long-term goal is to
understand the regulation of genome expression by chromatin and how mutations in chromatin
proteins contribute to oncogenesis, which may provide new ways of cancer treatment.

Public health relevance
PROJECT NARRATIVE The Cancer Genome Atlas (TCGA) Project has revealed that chromatin factors are highly mutated in human cancers. Our proposed studies aim to understand how these proteins cooperate and modify chromatin to regulate transcription. The research will reveal new interaction interfaces that can potentially lead to development of more specific drugs to treat cancer.